Proangiogenic M2-type macrophages and choroidal neovascularization

SUMMARY
Macrophages infiltrate the site of inflammation and polarize to either antiangiogenic M1-type macrophages or
proangiogenic M2-type macrophages, depending on the presence of various cytokines and other external
factors. Proangiogenic M2-type macrophages are major contributors to inflammatory angiogenesis in many
common diseases, in part by secreting proangiogenic factors, such as VEGF-A or IL-1b. Notably, M2-type
macrophages accumulate in areas of choroidal neovascularization (CNV) in patients with neovascular AMD. The
increase in M2-type macrophage-derived cytokines in eyes of patients with neovascular AMD has implicated this
cell population as a major driver of CNV pathogenesis. This hypothesis is further supported by the observation
of an accumulation of M2-type macrophages in laser-induced CNV or in a genetic VEGF-A-induced mouse
model of neovascular AMD. Ablation of macrophages in laser-induced CNV, which are predominantly M2-type
macrophages, blocked CNV, whereas administration of M2-type macrophages in the eye promoted CNV. Based
on these findings we propose that pharmacologic therapies that prevent M2-type polarization of macrophages
can serve as a novel approach to potently inhibit CNV progression in patients with neovascular AMD. The limited
understanding of the signaling mechanisms that are regulating M1- versus M2-type polarization of macrophages
has hindered the identification of molecular targets and pharmacologic inhibitors to selectively block M2-type
macrophage polarization. To address this unmet need, we have performed global quantitative time-course
proteomics and phosphoproteomics and identified kinase activation events that are associated with M1- versus
M2-type macrophage polarization. Furthermore, we identified in chemical screens pharmacologic inhibitors of
M2-type polarization that selectively block M2- but not M1-type polarization. Thus, the combination of these two
approaches provides us now with a unique resource to establish novel therapies that selectively block
proangiogenic M2- but not antiangiogenic M1-type macrophages in CNV. In proof-of-principle experiments we
can show that two of the identified inhibitors, the MEK inhibitor trametinib and the HDAC inhibitor panobinostat,
blocked M2-type macrophage polarization in CNV lesions and potently inhibited CNV lesion formation in laser-
induced CNV experiments. Our proposed experiments will test identified kinase and non-kinase inhibitors in a
systematic manner for their ability to selectively block M2-type polarization in detailed in vitro experiments as
well as in three well-established mouse models of neovascular AMD. Our proposal is based on extensive
preliminary data that provide a strong scientific premise. The proposed experiments have high rigor and
important clinical relevance and will likely lead to novel therapeutic approaches for neovascular AMD.

Public health relevance
NARRATIVE Based on our novel preliminary data we have identified pharmacologic inhibitors that can inhibit polarization of macrophages towards the proangiogenic M2-type population, which has been associated with progression of CNV. We hypothesize that selective pharmacologic inhibition of M2-type macrophage polarization can block CNV. Here, we will systematically test identified kinase and non-kinase inhibitors of M2-type macrophage polarization for their selectivity in blocking M2-type macrophage polarization and consequently CNV, with the aim to establish novel drugs for the treatment of neovascular AMD.